Multimodality and Longitudinal Artificial Intelligence for Diagnosis and Prognosis in Hepatic Steatosis

Project Summary
Metabolic dysfunction-associated steatotic liver disease (MASLD) affects approximately one-third of adults in
the United States. If left untreated, patients may develop more severe disease including steatohepatitis, cirrhosis
or hepatocellular carcinoma. There are significant challenges to diagnosis, prognostication, and treatment. In
MASLD, clinical biomarkers are crucial for guiding patient care, risk assessment, and outcome prediction in
medicine and include elevated alkaline phosphatase in the setting of biliary obstruction or hepatic loss of signal
on out-of-phase MR imaging in the setting of hepatic steatosis. However, predictive models have significant
limitations: (1) it is difficult to extrapolate risk models across tests or integrate multimodal data into a single model
and (2) the models use data only at a particular moment in time. This is the approach that most machine learning
models take and represents a significant limitation, as it is diametrically opposed to the approach that radiologists
take, which involves incorporating longitudinal data via comparison to prior imaging and leveraging the strengths
of multiple imaging modalities in conjunction with clinical data. This limited focus is a missed opportunity, with
the electronic health record (EHR) containing vast amounts of unused longitudinal and multimodal quantitative
and imaging data that can guide patient care. The investigators propose developing deep learning tools to predict
patient risk, synthetic clinical biomarkers, and normative data from multimodal and longitudinal health data. The
deep learning tools will be trustworthy and reliable, providing appropriate error estimates and confidence
intervals in the context of missing data. Building on our experience in deep learning for medical imaging and
multimodal satellite imagery data, in Aim 1 the investigators propose to develop novel deep learning techniques
that utilize multimodal and longitudinal health data to determine likelihood of MASLD. In Aim 2, the investigators
propose to determine the performance of these models in an out-of-domain cohort of patients and compare with
validated MASLD identification algorithms. The ultimate impact of this work will be new and highly accurate deep
learning models that predict outcomes related to cardiovascular disease, diabetes, and liver disease and result
in interpretable and actionable criteria for physicians.

Public health relevance
Project Narrative The purpose of this work is to develop trustworthy deep learning tools that predict metabolic dysfunction- associated steatotic liver disease risk in patients from multimodal and longitudinal medical imaging and electronic health record data. These models incorporate multiple imaging modalities (CT, MRI) and clinical data to leverage the advantages of the different modalities to predict clinical outcomes to guide patient management. The design of these algorithms is closer to how radiologists interpret images, and the output of these tools is explainable, informing clinicians about the reason for the model prediction.